Targeting the endocannabinoid signaling in chemical threat agents-induced lung injury

Summary:
The U.S. Department of Homeland Security (DHS) has identified over 200 chemicals of concern (CoCs) that
threaten public health, with approximately 25% posing respiratory risks. Notably, nitrogen mustard (NM) and
ammonia (NH3) are significant contributors to lung injury. Currently, there are no effective medical
countermeasures to mitigate NM- or NH3-induced lung damage, therefore, the search for an effective therapeutic
or prophylactic treatment persists. The endocannabinoids and their lipid-related mediators contribute to the
modulation of oxidative stress and lipid peroxidation and 2- Arachidonoylglycerol (2-AG), is the most abundant
endocannabinoid. 2-AG is produced ‘on demand’ and rapidly degraded, and monoacylglycerol lipase (MAGL or
MgII) is the main enzyme responsible for 2-AG catabolism. The hydrolysis of 2-AG by MAGL terminates the
activation of CB receptors, releasing free AA that serves as a precursor for the synthesis of pro-inflammatory
eicosanoids. Enhancing the 2-AG signaling displays an anti-inflammatory response to proinflammatory and
mechanical insults. Our preliminary findings indicate that acute exposure to NM or NH3 results in a significant
increase in MAGL in mouse lung tissue. The NM-induced increase in MAGL was significantly higher in lung
immune cells compared to alveolar epithelial and endothelial cells. A similar increase in MAGL was observed in
human alveolar macrophages (HAMs) in response to NM exposure. Furthermore, our pilot study showed that
the administration of JZL184, a potent and highly selective inhibitor of MAGL, resulted in a significant reduction
in NM- and NH3-induced acute lung injury and immune cell infiltration in mice. Given these promising indications,
this project aims to further investigate how augmenting the 2-AG signaling by inactivation of MAGL could confer
protection against NM- or NH3-induced lung injury. Aim 1: To determine the extent to which MAGL
inactivation/inhibition changes NM- or NH3-induced lung injury, inflammatory response, and toxicity. Aim 2: To
determine the cellular and molecular responses of MAGL inactivation on NM or NH3-induced lung injury and
inflammatory response. Aim 3: To delineate the mechanism by which MAGL inhibition/inactivation exerts the
protective effects in NM or NH3-induced acute lung injury and inflammatory response.

Public health relevance
Nitrogen mustard and ammonia are toxic chemicals, that remain a significant chemical threat due to their ease of synthesis and accidental or intentional exposure and currently, there are no effective treatments to mitigate lung damage induced by these chemicals. Using a mouse pre-clinical model, and human cells in this project we will aim to further understand the mechanism of lung toxicity and investigate, how augmenting endocannabinoid signaling could confer protection against chemical-induced acute lung injury.